Leveraging ΔFosB as a potential therapeutic for Alzheimer's Disease

PROJECT SUMMARY
There is an urgent need to develop effective strategies to combat memory impairments and cognitive decline in
Alzheimer’s disease (AD), but there is a serious lack of validated drug targets. Our team recently demonstrated
that the transcription factor FosB accumulates in the hippocampus, a brain region critical for learning, in AD
patients and AD mouse models. FosB regulates the expression of genes crucial for memory and learning,
and its accumulation in hippocampus drives cognitive deficits. We recently also demonstrated that FosB
binds DNA under control of a redox switch. This is intriguing because AD generates tremendous oxidative
stress in the brain. The exact pathological species of FosB that accumulates in AD is not known, i.e.,
whether the protein is oxidized and which of its binding partners are preferred. It is also not known exactly how
the redox switch works and how it could be targeted with small molecules. We do know that FosB has a well-
described role in drug addiction, accumulating in the nucleus accumbens, where it mediates the rewarding
effects of drugs of abuse by regulating the expression of many genes crucial to drug addiction. Through our
parent grant, we are developing chemical probes to investigate the mechanism of FosB in vivo and validate it
as a potential drug target to treat addiction. Our new findings suggest that FosB can also be leveraged to
counter cognitive decline in AD and serve as a biomarker to diagnose or predict early onset AD. We
hypothesize that the FosB redox switch and dimerization partner can be leveraged to render FosB
‘druggable’, enabling the design of compounds that bind FosB: 1) with high affinity, 2) with selectivity, and 3)
that regulate FosB function in a tunable manner (e.g., positively or negatively). Building on our success in
targeting FosB with compounds in our parent NIDA grant, we propose in this Administrative Supplement to
gather key preliminary data that can be used to validate FosB as a biomarker and therapeutic target for AD.
Our approach is to: 1) delineate the pathological species of FosB that accumulate in AD mice; 2) delineate
the mechanism of the redox switch through structure-based mutagenesis so that we can leverage its features
to design selective probes; and 3) identify a panel of novel compounds which selectively target the redox
switch of FosB using a newly designed cell-based assay. To this end, we already have a very strong,
translational research platform in place that draws on our prior work using animal models of cognition, an AD
mouse model, biochemical assays, medicinal chemistry, and structural biology. Thus, the positive impact will
be to determine the AD-relevant species of FosB and to develop strategies to rationally target them to
counteract cognitive impairment in AD. This proposal is also innovative because it develops a new AD animal
model and identifies novel, strategic chemical probes and critical mechanistic insight on the path towards
developing molecules that target FosB as novel therapeutics or diagnostics for cognitive decline in AD.

Public health relevance
PUBLIC HEALTH RELEVANCE This research is relevant to public health and the mission of NIH, because identifying the pathological species of FosB in animal models of Alzheimer’s disease (AD), dissecting the molecular mechanism of a druggable feature in the FosB molecule, and screening compounds against this feature will enable us to validate the therapeutic potential of FosB as a biomarker and novel target to treat AD. In particular, our probes could lead the way to develop radically new strategies to mitigate cognitive decline in AD, a major clinical hallmark of this devastating disease.